The Effect of the Home Environment on Health and Wellbeing of Low-income Older Adults

PROJECT ABSTRACT
In the face of a changing climate, there exists an urgent need to study the effects of the summertime home
thermal environment on the health and wellbeing of low-income older adults. We recently developed a platform
for continuous measurements of home thermal environment and daily measurements of sleep, gait, and
subjective wellbeing—all of which are either directly or indirectly influenced by thermal environment. Our first
aim is to determine cohort-level relationships between ambient temperature and outcomes related to sleep,
gait, and comfort, and examine the extent to which these relationships vary at the individual level. Our second
aim is to explore frailty and sex as potential effect modifiers of the relationships between home ambient
temperature and outcomes related to sleep, gait, and well-being in older adults living in subsidized housing.
Both aims will be completed by continuously measuring the home thermal environment of 50 low-income older
adults living in subsidized housing facilities in Boston for four summertime months. Participants will use a
validated wearable device to measure outcomes related to sleep, complete periodic smartphone-based
assessments of gait, and complete daily questionnaires to report their present subjective comfort. The
proposed study will establish that the home thermal environment has a substantial impact on health and
wellbeing of low-income older adults and will enable us to develop clinical interventions, public health
measures, and engineering solutions that minimize the impacts of hot weather on this vulnerable population.
The career development plan builds upon the applicant’s knowledge about the built environment and helps him
1) advance his clinical and practical knowledge of the effects of aging and age-related conditions (e.g., frailty)
on physiology and system function, especially as they relate to sensitivity of sleep, physical function, and other
meaningful patient-reported outcomes to environmental factors; 2) Gain experience in the conduct of research
involving low-income and/or underserved older adults and understand their specific needs; 3) Gain statistical,
professional, and leadership skills to develop and lead an independent research program focused on aging
and the built environment. The applicant will be working within a well-funded infrastructure that provides the
resources of numerous NIH- and foundation-funded grants. The resources available at the Marcus Institute for
Aging Research provide the intellectual expertise and support needed to conduct long-term at-home
monitoring of older adults, subject recruitment, and statistical analysis that are needed for the successful
completion of Aims. Additionally, Harvard Medical School provides numerous resources for career
development, including career development seminars and counseling, grant-writing courses, the scientific
cores of Clinical Translational Science Center (Harvard Catalyst); one of the world’s largest medical libraries,
and opportunities to apply for pilot grants and special courses to enable junior faculty to expand their expertise.

Public health relevance
PROJECT NARRATIVE A substantial number of low-income older adults are frequently exposed to a hot home ambient temperature, either because they cannot afford air conditioning, or they do not possess sufficient motor and/or cognitive ability to properly use it. The proposed research aims to understand the impact of the summertime variations in home thermal environment on health and wellbeing of low-income community-dwelling older adults. In the face of a rapidly changing climate, this is an urgently-need line of research that is expected to inform public health policy and lead to development of clinical and environmental interventions that are tuned unique needs of each older adult living within their built environment.